Admin-Core-001

Core A: Administrative Core Summary The primary goal of the Administrative Core is to facilitate collaborations among the component institutions and to support strong interactions with other AADCRC Centers. The Seattle Center grew out of existing collaborations between translational and basic scientists who focus on the immune basis of asthma and related immune disorders. The leadership of the component research programs share a focus on the airway epithelium as a central orchestrator of the immune response in asthma. This Administrative Core is designed to further facilitate collaborations among these existing programs and to utilize the strengths of each component institution towards this common purpose. The major goals of the Core are to facilitate scientific collaboration and productivity within the Seattle Center, facilitate interactions with other centers and the development of junior investigators, and identify projects that merit support through the Infrastructure and Opportunities Fund (IOF). We will further strengthen ties to other AADCRC programs to provide the infrastructure to support acquisition of key samples that are necessary to discover the alterations in the epithelium that are specific for asthma and the specific subtypes of this complex disease.